Human metabolic variation as a window into cancer initiation and progression

PROJECT SUMMARY/ABSTRACT
Metabolic reprogramming is a hallmark of malignancy and potential source of therapeutic targets. Recent work
indicates that metabolic liabilities change as cancer progresses, meaning that the pathways most relevant to
advanced cancers may not be apparent in locally-invasive, treatment-naïve tumors at the site of origin.
Recognizing the dearth of direct information about human cancer metabolism, we developed an approach to
probe the metabolic network of intact human tumors by infusing patients with stable isotope-labeled nutrients
(e.g. 13C-glucose) during tumor resection or biopsy. By measuring isotope labeling in metabolites extracted from
tumor samples and following the outcomes of patients who underwent this procedure, we identified metabolic
properties associated with poor survival. Of hundreds of metabolic features, 13C labeling in tricarboxylic acid
(TCA) cycle metabolites was the most predictive of cancer progression and early death. In non-small cell lung
cancer (NSCLC), patients whose tumors have high labeling of these metabolites succumb much earlier than
patients with low labeling, and blocking this pathway in mouse models of NSCLC suppresses metastasis. In
clear cell renal cell carcinoma (ccRCC), TCA cycle labeling is low when tumors are localized to the kidney but
much higher in metastatic tumors, and activating the TCA cycle promotes metastasis in mice. Therefore, in both
kinds of cancer, data from patients lead us to conclude that oxidative mitochondrial metabolism, particularly the
TCA cycle, electron transport chain (ETC) and oxidative phosphorylation (OxPhos), promote cancer progression.
The success of these experiments prompts us to further study the metabolic basis of human cancer progression
in the hopes of developing new insights and therapies. We propose three general directions. First, using a
combination of approaches in humans and mice, we will thoroughly examine how mitochondrial metabolism
stimulates metastasis to identify discrete metabolic dependencies that could be safely targeted in patients.
Second, we will develop approaches to discover new metabolic liabilities in human tumors. Strategies include a
pipeline to probe viable tumor explants with a series of isotope-labeled nutrients under physiological conditions
to choose the most informative tracers for isotope infusions in patients; and dynamic imaging methods to observe
and quantify informative aspects of metabolic flux in tumors in real time. Third, we will use the orthogonal
approach of studying human inborn errors of metabolism (IEMs) to discover why some metabolic anomalies
prime cells to become malignant. This approach capitalizes on a clinical cohort of over 1,000 subjects, including
patients with IEMs associated with highly penetrant cancers, and will provide unique insights into cancer initiation
and progression. Altogether these efforts will build on our long-standing productivity in human cancer metabolism
by uncovering new mechanisms governing the metabolic basis of cancer progression and producing new
methodologies to understand and treat lethal malignancies.

Public health relevance
PROJECT NARRATIVE Most cancer patients die when their tumors “progress” by metastasizing or becoming resistant to therapy. We developed techniques to study tumor metabolism directly in patients, and as a result discovered metabolic properties that promote cancer progression and early death. We will now 1) block these pathways to prolong survival in mouse models of cancer; 2) develop methods to discover more metabolic properties that drive cancer progression in patients and could be blocked with new therapies; and 3) use a unique orthogonal approach based on rare genetic diseases to discover how some metabolic defects prime cells to become malignant.